Combinatorial control of TLR signaling using self-assembly of immune signals on microneedle arrays to access the skin niche

Project Summary. Vaccines have been crucial technologies to prevent and stop the spread of global diseases, such as
smallpox and COVID. Despite these accomplishments, more robust vaccines are needed to combat existing and emerging
pathogens. To be effective, vaccines must contain at least two classes of signals: i) an antigen – the specific identifying
molecular sequence on a pathogen, and ii) an adjuvant – a signal to the cell that the antigen is dangerous. Specialized antigen
presenting cells (APCs) take up antigen and adjuvants in the periphery, then migrate to specialized immune organs known
as lymph nodes (LNs) to present antigen and additional markers to naive lymphocytes, such as T cells. T cells then return
to the periphery, destroying cells or pathogens displaying that same antigen. Specialized subsets of these APCs, dendritic
cells (DCs) and Langerhans cells (LCs), are concentrated in skin and dermal layers; thus, targeting vaccines to these cells
has potential to increase vaccine potency. DCs and LCs contain toll-like receptors (TLRs) in and on their surface, which
recognize toll-like receptor agonists (TLRas) - molecular patterns commonly found on pathogens but not mammalian cells.
Because activating TLRs induces inflammatory responses from these cells, TLRas are clinically used as adjuvants to
enhance vaccine responses against a variety of pathogens. Recent studies show that activating multiple TLRs can improve
disease outcomes compared to single TLRa delivery. One way to deliver multiple TLRas is by using biomaterials, which
can achieve controlled and targeted engagement of multiple TLRs on immune cells. Our lab has developed immune
polyelectrolyte multilayers, or iPEMs, comprised entirely of antigen and a TLRa. Injectable iPEM particles activate DCs
more potently than soluble signals. However, these materials do not specifically access the skin niche, where APCs are
concentrated. Microneedle arrays (MNAs) are emerging technologies being explored clinically that penetrate the skin via
projections long enough to reach concentrated APCs in dermal layers, but too short to trigger pain receptors. Motivated by
improved vaccine outcomes from combinatorial adjuvants, I have shown that constant amounts of antigen and varying
combinations of TLRas can be assembled on MNAs to develop a library of compositions. DCs treated with this library in
vitro presented antigen and costimulatory markers in a compositionally-dependent format. Funding of this proposal will
allow me to test the hypothesis that inclusion of two classes TLRas on MNAs maximizes APC activation at the site of
application. I will also link the relative TLRa compositions to APC migration to the LNs, resulting effector cell response,
and improvements in a melanoma model. These goals will be accomplished in three aims: 1) Connect defined ratios of
TLRas on MNAs to TLR engagement on skin-resident APCs in vitro, 2) Test how TLRa composition on MNAs polarizes
APC localization and T cell response in vivo. and 3) Use melanoma as a test bed to link TLRa composition on MNAs to
overall disease outcomes. These aims will provide understanding regarding the delivery of multiple TLRas via MNAs to
improve disease outcomes. Combined with my holistic training plan, the research planned in this F31 award period will
advance my ultimate goal of leading an independent research lab.

Public health relevance
Project Narrative Despite their success in eradicating many pathogens, there are still many diseases for which vaccines do not currently exist. One exciting way to improve vaccines is delivering antigens with multiple adjuvants directly to dermal layers, activating distinct pathways specifically against that antigen. This research proposal will probe how combinatorial vaccines induce effective immune responses by using microneedle arrays—small, polymer patches of needles hundreds of microns long— to painlessly deliver antigen with precise ratios of adjuvants directly to dermal layers.